ECM Stiffness as a Regulator of Tumor Cell Dissemination and Dormancy

We hypothesize that dense collagen matrices create a mechanical

Public health relevance
We hypothesize that dense collagen matrices create a mechanical